R35 Administrative Supplements to Recognize Excellencein Diversity, Equity, Inclusion, and Accessibility (DEIA)Mentorship

Abstract
This is a request for an administrative supplement to R35 HL139726 SOD3 regulation of redox
sensitive signaling in pulmonary vascular diseases to increase diversity, equity and inclusion in
biomedical research by supporting pre-doctoral student, Thi-Tina Nguyen. Thi-Tina Nguyen is a
predoctoral student in the Integrative Physiology Graduate Program at the University of
Colorado Anschutz Medical Campus and will be joining the Nozik lab in July 2022 for her PhD
thesis work. She meets criteria for this program based on being from a disadvantaged
background according to the NIH criteria. Ms Nguyen has identified an interest in studying how
maternal factors that impair EC-SOD expression lead to dysregulated redox signaling in the
lung and pulmonary vasculature of the offspring. Specifically, she plans to build upon the lab's
published observations that 1) insufficient EC-SOD (SOD3) worsens neonatal lung and vascular
development in neonatal mouse models, as well as chronic hypoxic pulmonary hypertension in
adult mice; 2) prenatal hypoxic exposure of pregnant rats reduced pup lung EC-SOD content; 3)
exercise increases placental derived EC-SOD in the maternal circulation and protects the fetal
liver; and 3) low EC-SOD content modulates macrophage reprogramming in pulmonary vascular
diseases. Based on these observations, Ms Nguyen has developed a research plan to
investigate how hypoxia in late gestation impacts lung EC-SOD, lung and pulmonary vascular
development and macrophage phenotype in the offspring after birth and into young adulthood.
This work will provide a foundation for an individual F31 application to expand upon this work.
The proposal outlines both the scientific proposal and a summary of the career development
plan for Ms. Nguyen.

Public health relevance
PROJECT NARRATIVE Redoxregulation mechanisms contribute to pulmonary vascular diseases.Extracellular superoxide dismutase is a key vascular antioxidant enzyme and low EC-SOD worsens pulmonary hypertension (PH) in both adult and neonatal models and regulates macrophage reprogramming in adult PH. This administrative supplement will support diversity graduate student, Thi-Tina Nguyen investigating the role of macrophage reprogramming in neonatal PH.